Leica Stellaris 8 Falcon/FLIM for the PennVet Imaging Core

Project Summary
In response to the expanding need for advanced live cell imaging capabilities, the University of
Pennsylvania School of Veterinary Medicine (SVM) established an Imaging Core facility in 2008. With the
involvement of a handful of pioneer labs, and with nearly $900,000 contributed by the University Provost's
office and Departments and Centers in the SVM, we purchased two microscopes including a Leica SP5
multiphoton system and a Leica/Yokagawa spinning disk confocal microscope. In 2011, with S10 support,
we acquired a Leica SP5/FLIM system and in 2016. with S10 support, we replaced our original Leica SP5
MP system with an SP8 MP microscope. Over the past 14+ years, our user base has grown to well over
100 individuals. Since its inception, data generated in the PVIC has contributed to over 150 manuscripts
and innumerable successful grant applications. Increased utilization of these instruments has been
facilitated by the expertise of our core director, Dr. Bruce Freedman and the core manager (since 2012) Dr.
Gordon Ruthel. Together with our users, the director and manager have implemented of a range of new
applications and capabilities. As a group we have an enormous collective expertise, including multiphoton
real-time imaging of pathogen infection and immune responses in the brain, intestine, skin, and secondary
lymphoid organs, as well as the behavior of tumors within the tissue matrix, multiphoton imaging of the
retina, FRET/FLIM based approaches to track the localization, interactions, and activity of signaling
molecules in response to receptor stimulation, photo-activation to generate signaling intermediates
instantaneously in situ, and live imaging of calcium and mitochondrial function. A particular specialty of the
PVIC is live cell and tissue imaging and FLIM/FRET based applications. Ongoing advances in imaging
technology offer the opportunity for our users to obtain a deeper understanding of physiological and
pathological mechanisms of cell and tissue function. Thus, this application seeks funds to modernize the
capability of the PennVet Imaging Core Our SP5 will no longer be fully supported by Leica beyond 2022.
Moreover, improvements in excitation flexibility with the newest pulsed white light laser. We propose to
replace our aging SP5/FLIM system, installed in 2011 with a Leica Stellaris 8 Falcon (fast FLIM)
microscope. Lifetime imaging capability, enhanced acquisition speed, dynamic improvements in temporal
resolution (Lightning), increased spatial coverage, greatly enhanced detection sensitivity of HyD detectors
afforded by the Stellaris 8 Falcon will have a transformative impact on NIH funded research of our users.

Public health relevance
Project Narrative: Funds are requested by the PennVet Imaging Core facility for a Leica Stellaris 8 Falcon microscope to replace an 11+ year old legacy Leica SP5/Picoquant Fluorescence Lifetime Imaging confocal microscope, which has been extensively utilized by a group of 50+ users to image intracellular and intercellular processes in living and fixed tissues and cells. As parts and maintenance for this older instrument will no longer be available, this new instrument with its increased capabilities is essential to continue and advance research of a highly active group of NIH funded scientists to address critical questions including the pathogenesis and treatment of retinal disease, stem and germ cell development, mechanisms of immunity to pathogens and vaccination, the pathogenesis of degenerative diseases, studies of the extracellular matrix and its role in disease, and cell signaling and intercellular communication.